A novel approach to treat non-alcoholic steatohepatitis (NASH)

Abstract
The goal of this SBIR fast-track application is to carry out a number of IND enabling studies on our siRNA drug
candidate, which is designed to treat non-alcohol steatohepatitis (NASH). NASH is a form of non-alcohol fatty
liver disease (NAFLD) and results from a pathological accumulation of fat in the liver. Approximately 5 million
people have been diagnosed with NASH in the US alone. NASH can lead to cirrhosis, followed by liver failure or
hepatocellular carcinoma. The projected number of diagnosed NASH patients worldwide is about 16 million. The
current primary treatment for NASH is lifestyle change. However, few patients remain adherent for extended
periods of time. No drugs have been approved in the US or other countries for treating NASH.
To address this unmet medical need, we are taking the innovative approach of treating NASH by increasing
mitochondrial metabolism in the liver. Fatty acids are transported to the liver where they are metabolized in
mitochondria through β-oxidation, which is coupled to the electron transport chain (ETC) and mitochondrial
respiration. Increasing the activity of the ETC in the liver could therefore speed up the degradation of fatty acids
and prevent their accumulation in the liver. A key endogenous negative regulator of the ETC is the MCJ protein
(MCJ/DnaJC15 or Methylation-Controlled J protein). MCJ is a mitochondrial protein that acts as a brake on the
ETC (“internal mitochondrial brake”). We have demonstrated that removal of MCJ is safe and results in increased
mitochondrial respiration without increasing the generation of reactive oxygen species. This is because removal
of MCJ minimizes electron leak by promoting the formation of respiratory supercomplexes.
In preliminary studies, we used mouse specific siRNAs to show safety of our approach and efficacy for reversal
and prevention of pathologies that are associated with NASH, using multiple mouse models of NASH. siRNA
has been validated as a drug for a number of diseases, with two siRNA drugs recently approved by FDA for
treatment of liver diseases (Patisiran and Givosiran). In addition, GalNAc (N-acetylgalactosamine) has been
used clinically to direct siRNA to liver hepatocytes. We have identified a lead siRNA that is cross-reactive for
human, NHP, and mouse MCJ. We have also developed proprietary GalNAc vectors and a lead siRNA-GalNAc
formulation (MITO-1041), but that formulation has not yet been tested in NASH models or for the rare occurrence
of polynucleotide liver toxicity. In Phase I, we will test for toxicity and efficacy. Back-up compounds have also
been identified to de-risk the program. Upon success of Phase I, we will apply to the NIH for Phase II funding. In
Phase II, we will carry out a number of IND enabling studies, as suggested by NIDDK. Following the success of
these studies, we will submit an SBIR Phase IIb proposal to manufacture GMP material, carry out the final GLP
tox studies in rat and NHPs, submit an IND, and carry out a first in human Phase I clinical study.

Public health relevance
Narrative Non-alcohol steatohepatitis (NASH) is a devastating disease for which there is no FDA approved treatment. NASH is an advanced stage of non-alcoholic fatty liver disease (NAFLD) that can lead to cirrhosis (liver failure) as well as hepatocellular carcinoma. While the frequency of NASH is very high in those with other metabolic disorders, such as obesity, diabetes, and/or hyperlipidemia (80%), about 15-20% of healthy population also has developed the first stage of the disease. About 5 million instances of NASH have been diagnosed in the US with advanced fibrosis and about 1.8 million individuals have progressed to cirrhosis. This is a proposal to develop the first FDA approved treatment for NASH.